Mechanisms of Glucose Dependence in Proliferating Cells

Despite an improved understanding of the metabolic vulnerabilities of some diseases, less progress has been
made on understanding whether targeting specific pathways, like glucose metabolism, would be effective and
tolerated as therapies. The long-term goal of this project is to understand the unique features of tissue-specific
metabolism in order to validate viable targets for specific diseases. The overall objective of this proposal is to
characterize the impact of a prototype metabolic therapy, the inhibition of glucose transport, on the metabolism
of normal and hyperproliferative epidermal tissues. The central hypothesis is that genetically and chemically
inhibiting glucose transport will prevent pathological hyperplasia, without affecting the normal function of the
skin. This hypothesis is based on the novel finding that Glut1 deficient skin undergoes transcriptional and met-
abolic reprogramming to allow for normal skin function and homeostasis, but is unable to proliferate in re-
sponse to physiological stressors. A thorough understanding of the principles that underlie the differential met-
abolic requirements of normal and proliferating tissues will validate glucose transport inhibition as a therapeutic
target and facilitate the development of additional, novel therapies to target tissue-specific metabolism. This
proposal will be achieved through three aims: 1) Determine how genetic inhibition of glucose transport rescues
acute, imiquimod-induced psoriasiform hyperplasia. Glut1 deficient skin will be analyzed through histology,
gene expression, and metabolomic assays. The impact of genetic inhibition of glucose transport and induced
hyperplasia on metabolic flux will be assessed through established in vivo 13C isotopic labeling. 2) Determine
whether the topical application of small-molecule inhibitors of glucose transport can a) improve markers of hy-
perplasia in organotypic skin equivalents, and b) reverse chronic, UVB-induced hyperplasia in hairless mice.
The topical application of small molecule inhibitors of glucose transport will first be optimized in organotypic
cultures, and then those inhibitors will be tested for their ability to affect chronic hyperplasia in organotypic cul-
ture models and in UVB-irradiated, hairless mice. 3) Assess whether pathways already implicated by the loss
of Glut1 in mice are also affected in biopsies from patients who develop pathophysiological overexpression of
Glut1. Completion of these proposed goals will facilitate the development of glucose transport inhibition as po-
tential therapy for diverse hyperplastic skin diseases, including psoriasis, and also will significantly advance our
understanding of how metabolism is regulated in normal and disease processes in vivo. Experts in genetics,
molecular cell biology, metabolomics, pathology, and clinical patient registries will collaborate to assess the
impact of targeting a specific metabolic pathway on multiple models of disease.

Public health relevance
Psoriasis affects more than 7 million people in the US. Excess skin proliferation contributes to the development of psoriasis and many symptoms of the disease. Rapidly dividing cells have differing metabolic requirements and require more glucose metabolism than resting cells. These differential requirements have highlighted the inhibition of glucose transport as a novel therapeutic approach for hyperproliferative skin diseases, like psoriasis. The proposed studies will provide fundamental insights into skin metabolism and provide evidence for the safety and efficacy of the inhibition of glucose transport as a novel therapy.